The roles of Anaplasma phagocytophilum surface proteins in infection

Human granulocytic anaplasmosis (HGA) is a potentially fatal infection and the second-most common tickborne
disease in the United States. Its incidence is increasing at an alarming rate. Indeed, the 39% rise in the number
of cases from 2016 to 2017 is greater than for any other tickborne infection. Even more concerning, the true
incidence of HGA in this country is estimated to be 10- to 50-fold higher. The causative agent of HGA is
Anaplasma phagocytophilum, an obligate intracellular bacterial pathogen that exhibits an unusual tropism for
neutrophils. Like all obligate intracellular bacteria, Ap must invade cells to survive and cause disease. Identifying
the adhesins and their host cell receptors that facilitate this essential step is fundamental to understanding Ap
pathogenesis and preventing HGA. During the prior funding period, we identified three adhesins called Asp14,
AipA, and AipB that Ap expresses when it converts to the infectious form and during tick transmission feeding
on mammalian hosts. Hence, they are ideal targets for neutralizing infection. The adhesins’ receptor binding
domains are Asp14 residues 113-124 (Asp14113-124), AipA residues 9-21 (AipA9-21), and AipB residues 80-94
(AipB80-94). An antibody cocktail against all three domains robustly inhibits Ap infection of host cells, whereas
targeting only one or two is less effective. Therefore, they function cooperatively, are compensatory, and maximal
blockade of Ap infection is achievable by disrupting the full cohort of adhesin-receptor interactions. Asp14 binds
protein disulfide isomerase (PDI) on the neutrophil surface, which brings Ap in sufficient proximity to PDI such
that it reduces bacterial surface thiols as a key step in infection. AipB is a PDI substrate that potentially binds
CD18, a 2 integrin component and newly discovered Ap receptor. AipA and CD13 are a third Ap adhesin-
receptor pair that is critical for invasion. PDI, CD13, and CD18 cluster in lipid rafts, which are essential platforms
for Ap entry. Moreover, signaling events that CD13 and CD18 elicit are associated with Ap infection. Mice
immunized against Asp14113-124 and/or AipA9-21 are significantly, but incompletely, protected from Ap challenge.
Thus, Asp14 and AipA are important for Ap infection in vivo and their receptor binding domains are protective
antigens. For our competitive renewal, we will build on these compelling data. We will dissect how the AipA-
CD13 and AipB-CD18 interactions orchestrate Ap uptake into host cells and define the relevance of AipB to Ap
infection in vivo. We will determine the protective capacity of AipB alone and in cooperation with AipA and Asp14
against syringe-mediated and tick-transmitted Ap challenge. Completing the proposed aims will yield the most
comprehensive understanding of adhesin-receptor interactions for any rickettsial agent and one of the most
refined models for the molecular basis of infection among intracellular bacterial pathogens. This fundamental
knowledge will benefit design of approaches for protecting against HGA and significantly advance the field.

Public health relevance
Human granulocytic anaplasmosis (HGA) is an emerging, potentially fatal tick-transmitted disease caused by a bacterium that invades white blood cells called neutrophils. The proposed research will functionally dissect surface proteins of the HGA agent and assess if immunizing against them protects against infection. These studies will benefit design of strategies for preventing HGA.